von Willebrand factor and thrombocytopenia in infective endocarditis

PROJECT SUMMARY
Infective endocarditis (IE) is a serious and often deadly disease in which bacteria colonize the heart valves and
cause severe damage. The exact prevalence of the illness has been difficult to define due to diagnostic
challenges; however, of the thousands of cases diagnosed annually around the world, as many as 40% of them
are fatal. The high mortality rate of IE is due mostly to ineffective treatment options, which are currently limited
to aggressive antibiotic treatments and cardiac surgeries. IE caused by the Gram-positive bacteria
Staphylococcus aureus has been the deadliest and most common form of IE for over a decade. Recent clinical
data demonstrate a correlation between platelet levels in circulation and severity of IE, as patients who develop
thrombocytopenia, or low platelet levels, have lower chances of survival compared to patients with normal
platelet levels. Additionally, S. aureus expresses two proteins, von Willebrand factor binding protein (VWbp) and
staphylococcal protein A (SPA), that bind von Willebrand factor (VWF), a large plasma protein that mediates
platelet adherence to the endothelium and facilitates platelet clearance from the bloodstream. Animal models in
which VWF is absent exhibit reduced bacterial colonization in both the heart and endothelial tissue. Clinical data
and basic research have therefore implicated VWF as a critical mediator in the early development and later
progression of IE, yet the molecular mechanism underlying this role of VWF is unknown. Recently, our lab
identified the autoinhibitory module (AIM) in VWF that limits its association to platelets. Our lab has also
elucidated the molecular mechanisms of platelet activation and clearance when VWF binds and stimulates
platelet receptor GPIba under shear flow. Aberrant binding of VWF to GPIba can lead to enhanced platelet
activation and cause thrombosis or increased platelet clearance which leads to thrombocytopenia. We
hypothesize that S. aureus proteins SPA and VWbp facilitate early bacterial colonization and later
thrombocytopenic conditions by activating VWF to enhance platelet binding and yield platelet activation and
clearance. In Specific Aim 1, we will determine how SPA and VWbp affect VWF autoinhibition by assessing
changes in binding and AIM dynamics. In Specific Aim 2, we will investigate how these S. aureus proteins
modulate VWF-mediated platelet activation by assessing binding of VWF and GPIba in the presence of these
proteins, measuring hallmarks of platelet clearance signals via flow cytometry, and determining the ability of
these proteins to facilitate platelet clearance in mice. My proposed studies will elucidate a molecular mechanism
underlying S. aureus pathogenesis and IE development to facilitate potential therapeutic strategies as well as
contribute to our fundamental understanding of hemostatic and thrombotic regulation during bacterial infection.

Public health relevance
PROJECT NARRATIVE Bacteria entering the bloodstream can cause serious and deadly infection, including infective endocarditis, in which bacteria bind to and severely damage the heart. This project aims to further understand how specific bacterial proteins interact with proteins in the blood. The results obtained will guide future development of therapeutics that will mitigate the severity of bacterial infections that lead to infective endocarditis.